Serious mental illness and incarceration: piloting the use of a multi sector linked administrative dataset

Project Summary/Abstract
Mass incarceration of individuals with serious mental illness (SMI) is a public health and human rights crisis.
Not since the mid-nineteenth century has the criminal justice system played such a large role in how American
society responds to mental illness. Since the late 1960s researchers have noted ever-rising numbers of jail
inmates with SMI, often caught in a "revolving door" of hospitalization, homelessness, and arrest. Incarceration
is one of the most visible (and traumatic) moments of contact with the public system, and provides a window
into the failures of the public mental health system. Our long-term objective is to inform and rigorously evaluate
policy and interventions that seek to reduce law enforcement response to mental illness and end the mass
incarceration of individuals with SMI. In line with NIMH Strategic Objectives 4.1B and 4.2, this R34 proposal
furthers the development of a real-world data collection system to facilitate research and ongoing monitoring
related to access, service continuity, equity, and outcomes such as incarceration and homelessness in diverse
populations and settings. Our research approach is to leverage a regularly-updated Los Angeles County (LAC)
county-wide administrative database, which links individuals across 8 public agencies from 2010 to the
present, for research around incarceration and SMI. In partnership with LAC administrators/providers and non-
LAC researchers, we will develop and test this database through algorithm development and validation,
exploration of mental health service patterns leading up to incarceration, and testing of the algorithms and
dataset using a pilot evaluation of mental health crisis interventions in lieu of law enforcement response, in
preparation for an R01 proposal to evaluate the effects of policies and interventions that shift resources from
criminal justice to new and existing mental health services. LAC as our study site allows for a particularly in-
depth look because of its size (population>10 million) and diversity across a number of critical divides:
urban/rural; racial; economic; cultural; and resource availability. Our specific aims are as follows: Aim 1:
Develop algorithms for sample ascertainment and operationalization of key measures to enable the study of
criminal justice contact and diversion programs among underserved populations with SMI. Aim 2: Validate and
refine these algorithms through formal validation methods and in consultation with our partners. Aim 3: Test the
feasibility of research using the linked dataset and algorithms by asking what types of service patterns precede
incarceration of individuals with SMI and how these patterns differ across geographic and demographic
subgroups, and by conducting a pilot evaluation of alternative crisis response interventions: who receives
them, what their service patterns look like before and after the crisis service, how this differs between clients
who receive a new mental health-only 911-dispatched service vs. a joint law enforcement-mental health crisis
intervention team service, and how this compares to similar clients who had a police contact leading to arrest.

Public health relevance
Project Narrative Policies and interventions that seek to reduce the incarceration of individuals with serious mental illness and reduce the role of law enforcement in responding to mental health crises are of great importance to public health. To inform and facilitate evaluation of these policies and interventions, we will further the development of a large, existing, continually-updated county-wide dataset linked across 8 public agencies in Los Angeles County, which will (a) facilitate research that can identify and evaluate strategies for improving access, continuity, and equity of mental health services among some of the most vulnerable and potentially unserved individuals with serious mental illness and (b) facilitate ongoing monitoring of access, service continuity, equity, and outcomes such as incarceration and homelessness in diverse populations and settings. We will work with partners from Los Angeles County agencies and researchers from other geographic areas to develop approaches for identifying key information in the data—individuals with serious mental illness; key events such as mental health diversion services, alternative crisis services, arrests, and incarcerations; episodes of outpatient mental health services or homelessness; and service patterns before or after key events—and we will test the use of these linked data and approaches in an evaluation of alternative mental health crisis services in Los Angeles, in preparation for future research on policies and interventions that seek to reduce incarceration and law enforcement response to individuals with serious mental illness.